Impact of a new group 6 serotype on pneumococcal vaccines

[unreadable] DESCRIPTION (provided by applicant): Pneumococci, including those with capsular polysaccharides (PSs) of types 6A or 6B are significant human pathogens. 6A and 6B serotypes produce structurally similar but serologically distinct capsular PSs. We discovered subtypes within 6A serotype (named 6Aα and 6Aβ) with monoclonal antibodies and discovered alleles of wciN (named wciNα and wciNβ), a putative glycosyl transferase in capsule gene locus. 6Aα represents the classical 6A and appears to have wciNα. Although less common than 6Aa strains, 6Aβ strains are found worldwide, can be pathogenic, and appear to have wciNβ. Further, current pneumococcal vaccines, which contain 6Bα PS, appear to elicit cross-opsonic antibodies to 6Aα regularly but not to 6Aβ. (We labeled the 6B strains with wciNα and wciNβ as 6Bα and 6Bβ, respectively. 6Bβ strains have not been observed.) Since 6Aβ may be able to avoid vaccine-induced host immunity, 6Aβ strains may replace 6Aa strains with continued vaccine use with resulting reduction in vaccine efficacy. To investigate this potential, we hypothesize that serogroup 6 has two new serotypes (6Aβ and 6Bβ) associated with the wciNβ allele and that the new serotypes produce new capsular PSs, are poorly covered by current pneumococcal vaccines, and may increase in prevalence with vaccine use. To examine our hypothesis, we will: (A) Study the role of the wciNβ allele on the 6Aβ and 6Bβ serotypes by determining the DNA sequence of the capsule gene locus of 6Aβ, by replacing the wciNα allele of 6Aa with the wciNβ allele of 6Aβ, and by elucidating the molecular structure of 6Aβ PS with biochemical analyses. (B) Evaluate pneumococcal vaccines for their abilities to elicit antibodies capable of opsonizing the 6Aα, 6Aβ, 6Bα, and 6Bβ serotypes among elderly adults and young children, and evaluate 6Aβ PS for its ability to elicit opsonic antibodies to the four serotypes. (C) Study the effect of pneumococcal vaccination on the 6Aβ subtype by determining the prevalence and evolutionary relationship of 6Aβ isolates obtained in various parts of the world before and after clinical use of a 7-valent conjugate vaccine. Our research interest has been the study of cross-protection induced by pneumococcal vaccines. In the last funding period, we predicted vaccines may not elicit cross-protection to some serotypes. Building on our discovering the 6Aβ serotype, we will investigate the effect of unrecognized serotypes on vaccine-induced cross-protection. Our study will increase the understanding of the serotype shifts and replacements that follow pneumococcal vaccination, an important national health care tool. Also, our studies of 6Aβ should yield an elegant model showing how an emerging pathogen can appear, spread, and react to altered host immunity. [unreadable] [unreadable] [unreadable]